Elucidating the Cellular Origins of lung adenocarcinoma

Lung cancer is responsible for the most cancer-related deaths in the United States, and Lung
adenocarcinoma (LUAD) is the major histologic subtype. LUAD presents clinically with four major histologic
subtypes (lepidic, acinar, papillary and solid), has variable presentation of EGFR and Kras mutations
depending on ethnicity, age, and sex, and can be subclassified into four separate categories based on
genome-wide DNA methylation profiles. To date, there is little connection between these widely disparate
manifestations of LUAD besides their effects on overall patient survival. There is evidence in mouse models
to suggest that the majority of LUAD arise from surfactant protein c (Sftpc)-positive alveolar epithelial type
2 (AT2) cells, and that Scgb1a1-positive club cells can also contribute a fraction of LUAD cases. However,
it is unknown if LUAD can arise from AT1 cells, the other major epithelial cell type in the distal lung that
covers 95% of the alveolar surface. AT1 cells were historically thought to be terminally differentiated.
However, we have recently developed a Gramd2-driven CreERT2 mouse model that specifically activated
the KrasG12D oncogenic driver in AT1 cells, and found that AT1 cells can serve as a cell of origin for LUAD
with predominantly papillary histology and distinct transcriptomic signatures, including increased
transforming growth factor beta (TGF-β)-mediated epithelial to mesenchymal transition (EMT). This is in
contrast to AT2 cell-specific Sftpc-driven KrasG12D, which resulted exclusively in lepidic LUAD and was
enriched for VEGF-mediated angiogenesis. Therefore, we hypothesize that LUAD, as it is currently defined,
may actually be a collection of at least 4 adenocarcinoma subtypes that arise in the distal alveolar
compartment from different cells of origin, and that the great variation we see in LUAD presentation and
clinical outcome can be explained in part by which cell type LUAD arises in. However; several questions
remain. We do not know if the oncogenic driver in AT1 cells influences histologic presentation. We will
therefore (Aim 1) characterize Gramd2-CreERT2 driven EGFR mutations, the other major oncogenic driver
in LUAD. It is also possible that induction of KrasG12D in AT1 cells results in disrupted tumor
microenvironments that stimulate AT2 cells; we will therefore (2) perform GFP+ lineage tracing to determine
in vitro and in vivo cell contributions to tumor formation. We will also establish the translational implications
of our prior research (Aim 3) and utilize inhibitors of TGFβ that have succeeded in preclinical models but
failed in clinical trials to determine if cell of origin influences response to therapy in both mouse models and
unique human patient LUAD cohorts. Understanding the connection between cell of origin and clinical
presentation will allow for enhanced patient stratification, improved assessment of best therapeutic
outcomes, and potential reclassification of LUAD into multiple cancer types.

Public health relevance
PLung adenocarcinoma (LUAD) is the largest subtype of lung cancer and has significant heterogeneity in terms of what the cancer cells look like and how well patients survive. LUAD arises in the air sacs, which consist of surfactant-producing AT2 cells with known roles in cancer and large, flat gas-exchange facilitating AT1 cells that had been thought to lack the ability to serve as a cell of origin for cancer. Here we investigate the role of AT1 cells in LUAD development, which shifts the current paradigm and establishes that AT1 cells can become cancerous and give rise to one type of LUAD and may lead to better patient classification and new therapeutic strategies.